EXPERT COMPUTER SYSTEMS FOR PHYSICIAN CRITIQUE PLANS

The proposed research will explore the critiquing approach to computer advice in medicine. The emphasis will be to explore the system design issues involved in building computer systems which critique a physician's own plan for patient care. To explore these design issues, we are implementing several developmental critiquing systems in different areas of medicine. The proposed research will continue this work: VQ-ATTENDING VQ-ATTENDING is currently under development to critique aspects of the ventilator management of a patient receiving mechanical respiratory support. The implementation of this system will continue, and design issues of its "goal-directed" structure will be explored. HT-ATTENDING HT-ATTENDING is designed to critique the pharmacologic management of essential hypertension. HT-ATTENDING will be refined and its knowledge brought up-to-date. Critiquing Differential Diagnosis - A further plan is to extend the critiquing approach into a domain of differential diagnosis. To explore these design issues, we will use the domain of syncope. ESSENTIAL-ATTENDING - A broader goal is to develop a domain-independent "system-building system" to facilitate the implementation of critiquing systems in still other domains. The implementation of VQ-ATTENDING, HT-ATTENDING, and the diagnostic syncope system, using ESSENTIAL-ATTENDING, will allow us to explore domain-independent design issues in a robust fashion.